Ultrahigh-Sensitivity Mass Spectrometry for Scalable Proteomics

The protein composition of a cell, or proteome, responds dynamically to external and internal environments,
and provides fundamental information on biomolecular mechanisms. However, research in these primary
effectors in cellular function is constrained by the lack of high-sensitivity mass spectrometry (MS) approaches
necessary to characterize proteomic changes, such as aging effects across neurons, subtypes of neurons, or
neuronal subcompartments and in/between samples at trace abundance, such as in the cerebrospinal fluid. At
the biological level, aging results from accumulated cellular damage over time, and has been associated with
deterioration of synaptic composition, dysregulation of excitatory/inhibitory balance of neuronal circuits, and
deleterious proteolytic processing. Here, a new proteomics platform, termed scalable Single-Cell Mass
Spectrometry (SCeMaS), will be developed and validated on biological models of proteins and protein
fragments associated with these biomolecular effects of aging via three independent aims. Each aim is
designed to address contemporary technical limitations that have historically hindered deep MS `omics and
integration with functional tools of research on aging, such as electrophysiology. This project strategically
leverages invertebrate and vertebrate biological models based on their (i) practical advantages to facilitate
specific aspects of technology development, refinement, and validation as well as (ii) established use in
various contexts of research on aging. Giant identified neurons of the crayfish are chosen to advance the
technology of proteome collection and processing with reduced protein/peptide losses than presently feasible.
Specific single neurons will be patched in the mouse to downscale the approach through development of a
sample-enrichment method. To enable recording of live neurons in these models and microanalysis of
proteome degradation in the CSF, a specialized chemical approach will be introduced to remove salt
interferences, thus ushering MS proteomics and electrophysiology to a one-step process. Using limited
populations of cell lines modeling Alzheimer's disease and neuronal subcompartments, MS sequencing will be
advanced by developing a “smart” data acquisition method that alleviates current bottlenecks in bandwidth.
SCeMaS will be validated using each of these biological models, where representative biomarkers are known
and compared to healthy adult samples, aging neural proteomes are expected to be less diverse and show
disrupted stoichiometries and/or homeostasis consistent with abnormal protein production, aggregation, and
proteostasis. This project includes a multidisciplinary team that combines strengths in instrumental
bioanalytical chemistry, aging, neuroscience, biochemistry, and bioinformatics to identify proteomic changes
during healthy aging, accelerated aging in progeria, and in neurodegenerative disease. SCeMaS will enable
scalable and deep MS-based proteomics-peptidomics under physiological conditions, thus expanding the
bioanalytical toolbox of research on aging in these and other biological models.

Public health relevance
Research on aging is currently hindered by a lack of high-sensitivity technologies capable of characterizing proteins in limited cell populations and biopsies. This proposal will develop a next-generation ultrahigh- sensitive instrument to enable the deep analysis of proteins in important biological models of aging.